BRANCHED CHAIN AMINO ACIDS IN TRAUMA

The research proposed is designed to identify and characterize metabolic benefits of an amino acid formula enriched with branched chain amino acids (BCAA) compared with a balanced amino acid mixture in the nutritional support of injury metabolism. The paired studies described would utilize a controlled, reproducible human model of injury metabolism. Specifically they would: 1. determine the relative efficiency of BCAA enriched and balanced amino acid mixtures in achieving nitrogen equilibrium during induced injury metabolism; 2. characterize the metabolic alterations induced in this model when nitrogen equilibrium was maintained both with BCAA enriched and balanced amino acid mixtures; 3. determine differences in those responses noted above (#2) that could be attributed to the composition of the nitrogen source.